Clinical Support

I have participated as a Medical Oncology consultant for the NINDS team studying novel pain therapeutic RTX. I continue to support the Surgical Oncology program by providing Medical Oncology advice at the GI Tumor Board. I continue to teach Medical Oncology fellows as a preceptor in clinic and by giving yearly lectures on pancreatic cancer. Further, I organize the monthly interdisciplinary pancreatic cancer journal club and regularly present new articles at the GI Medical Oncology Journal Club that is attended by both clinical fellows and GI Onc providers.